Development of advanced voltammetric method for basal neurotransmitter level measurement

PROJECT SUMMARY
We propose to develop and optimize an advanced neurochemical recording technique that would be able to
measure relatively rapid physiologically representative second-to-second changes in basal concentrations of
specific neurochemicals, such as dopamine, in the brains of awake behaving animals. Microdialysis, a
commonly used in vivo sampling technique, is able to measure changes that occur in basal levels. However, in
practice the sampling timescale is significantly limited to minute-to-minute changes and it suffers from poor
spatial resolution and induces significant tissue damage. As well, conventional in vivo electrochemical
recording techniques, such as fast-scan cyclic voltammetry, are intrinsically limited to measuring phasic
(stimulation-induced) changes in neurochemical concentrations and not changes in basal concentrations. The
proposed electrochemical technique we call Multiple Cyclic Square Wave Voltammetry (M-CSWV) will enable
second-to-second measurements of basal extracellular levels of neurochemicals with exceptional spatial
resolution, sensitivity, specificity, and minimal tissue disturbance. This proposal leverages our unique expertise
in neuroscience, electrochemistry, software development, and engineering to develop and validate this novel
neurochemical recording technology for broad use in basic neuroscience research, clinical brain
neuromodulation, and a variety of electrochemical applications. Our initial animal studies will guide and inform
the application of our investigational technique for use by the general neuroscience and medical community.
Our proposal seeks to (1) establish M-CSWV as a reliable research tool that is capable of identifying and
quantifying basal dopamine extracellular levels in vivo with unsurpassed sensitivity and selectivity; and (2)
validate the use of M-CSWV for in vivo chronic selective measurement of basal dopamine concentrations and
application in an animal model of drug-induced neurochemical sensitization.

Public health relevance
PROJECT NARRATIVE Neurochemicals in the brain, such as dopamine, transmit information between neurons to process input and produce normal behavior, but that occasionally when their levels are disrupted lead to neurologic and psychiatric disorders. We have developed a novel neurochemical recording method called Multi-Cyclic Square Wave Voltammetry that for the first time measures basal neurochemical concentrations in real-time in the brain with single-second time resolution and unprecedented chemical selectivity. Furthermore, we propose to standardize this novel technique for use in neuroscience research directed to understanding the neurochemical basis of neuropsychiatric diseases by demonstrating its capability to quantify basal levels in a well-known animal model of drug-induced neurochemical and behavioral sensitization.